3D diagnosis of Hirschsprung disease using open-top light-sheet microscopy

Abstract
Hirschsprung disease is a congenital defect that affects an estimated 1:5000 liveborn infants. It
is characterized by absent ganglion cells (neurons) in the distal rectum and a variable length of
contiguous proximal bowel. The diagnosis of Hirschsprung disease relies upon subjective
pathologist interpretation of up to 100 tissue sections from suction rectal biopsies to prove the
absence of ganglion cells and the presence of hypertrophic nerves. Due to the labor-intensive
and time-consuming nature of the current diagnostic process, there is a need to more efficiently
and comprehensively diagnose Hirschsprung disease. Our team has pioneered the use of 3D
open-top light-sheet (OTLS) microscopy, which enables rapid, high-throughput imaging of large
clinical samples. In combination with cutting-edge machine learning techniques, we hypothesize
that 3D OTLS microscopy can provide more accurate and consistent assessment of ganglion
cells and hypertrophic nerves in suction rectal biopsies from patients with suspected
Hirschsprung disease. We will test this hypothesis by developing a multiplex staining protocol
and machine learning analysis pipeline, which will be piloted on 100 rectal biopsy specimens
from fresh resection specimens.

Public health relevance
Narrative Hirschsprung disease is a congenital defect that is characterized by absent ganglion cells (neurons) in the distal rectum and a variable length of contiguous proximal bowel. The diagnosis of Hirschsprung disease currently relies upon labor-intensive, time-consuming, and subjective methods. We propose to use 3D open-top light-sheet microscopy and machine learning to provide more accurate and consistent assessment of ganglion cells and hypertrophic nerves in suction rectal biopsies from patients with suspected Hirschsprung disease.